Multidisciplinary Training Program in Lung Disease Supplement

DESCRIPTION (provided by applicant): This application is a competitive renewal of the present Multidisciplinary Training Program in Lung Disease (HL07749). The goal of the program is produce outstanding biomedical scientists who investigate the manifestations, mechanisms, prevention, and treatment of pulmonary disorders. The program proposes to support 12 postdoctoral fellows (M.D.s and Ph.D.s) per year. The investigative approaches available to trainees include disciplines applicable at the molecular, cellular, tissue, organ, whole animal and clinical population levels. The program utilizes faculty trainers from the Medical School, School of Public Health, the College of Pharmacy, and the College of Engineering at the University of Michigan. Medical School faculty trainers are appointed in the Departments of Internal Medicine, Pathology, Radiology, Human Genetics, Microbiology & Immunology, Molecular and Integrative Physiology, Neurology, and Pediatrics. The School of Public Health trainers are appointed in the Departments of Epidemiology and Biostatistics. The College of Engineering trainers are appointed in the Department of Biomedical Engineering. A close relationship between a primary mentor and a co-mentor(s) with the trainee is the foundation of the training experience. This laboratory experience is supplemented by a core group of lectures; workshops, core conferences, and training in responsible research conduct, career planning, communication skills, and grant writing. Emphasis is placed on personal instruction specifically designed for individual trainees. New faculty and core lectures have been added to further solidify the disciplines of bioinformatics, genetics, metabolomics, and proteomics. Considerable emphasis has been placed on multidisciplinary interactions and providing opportunities to develop academic careers in areas of scientific need. Emerging areas of growth in our program include host-microbe interactions, transplantation biology, progenitor cell biology; health services research and multi- institutional disease-specific clinical networks for research. Postdoctoral trainees in the clinical sciences can acquire a Master's Degree from the School of Public Health. A broad range of research topics is available to trainees including the pathobiology of fibrotic lung disease, host defense mechanisms, lymphocyte-macrophage interactions, epithelial cell biology, fibroblast biology, tumor biology, eicosanoid biochemistry, granulocyte biology, progenitor cell biology, bioinformatics, epidemiology, outcomes in lung disease, physician decision making, economic assessment of medical interventions, appropriate utilization of medical technology and medical ethics. Fellows and mentors are reviewed by a committee that monitors the training and career development of fellows and promotes mentoring skills. Over the past 5 years, 6 underrepresented minorities have completed our training program. Eighty eight (88%) of graduates trained in the past 10 years are currently in academic or equivalent positions, indicative of the program's success

Public health relevance
The University of Michigan Multidisciplinary Training Program in Lung Disease provides research training for M.D. and Ph.D. scientists in both laboratory-based and clinical studies. The purpose of this training is to produce outstanding biomedical scientists who investigate the manifestations, mechanisms, prevention, and treatment of lung disease.